Maternal Obstetric Monitoring System (MOMS): a Postpartum Hemorrhage (PPH) Wearable Monitor

PROJECT SUMMARY/ABSTRACT
This proposed project is responsive to the continued need for improved early detection of postpartum
hemorrhage (PPH). PPH is the leading causes of death in pregnant women. Data from multiple published studies
strongly suggest that vital signs alone are not actionable during the early stages of PPH. Blood volume loss as
great as 30% can occur with current standard vital signs remaining clinically normal. In these stages,
compensatory mechanisms for volume loss result in delayed changes in vital signs. Changes in vital signs such
as blood pressure often occur only when cardiovascular collapse is imminent, which is often too late to provide
a life-saving intervention as the victim enters a state of circulatory shock. The objective of the proposed grant is
to develop a robust wearable system, which we call Maternal Obstetrics Monitoring System (MOMS), that can
measure high-quality physiological waveforms, from multiple sensors integrated into one easy to wear device,
for hospital as well as ambulatory monitoring. We will test the hypothesis that continuous monitoring and analysis
of vital sign waveforms with MOMS is a more accurate, precise, and robust early indicator of PPH than current,
commercially available technologies. The R61 Specific Aims are 1) to complete and validate the alpha prototype
sensor integrating the MEMS-based blood pressure sensor and the CSI sensor and 2) to determine design
requirements of the R33 beta prototype from design inputs obtained from shadowing, interviews, and focus
groups. The R33 Specific Aims are 1) to design and develop the beta prototype per design specifications of R61
Aim 2, 2) to test this beta prototype with a validated lower-body negative pressure protocol of hypovolemia, and
3) to build multimodal machine learning (MMML) algorithms integrating the multimodal data streams for
predictive capabilities and perform explainability analysis. To achieve these aims, we have assembled a
multidisciplinary research team with expertise in biomedical device design, biophotonics, clinical obstetrics and
gynecology, and machine learning. With the successful completion of the proposed research, we will possess a
validated MOMS sensor technology that is ready for use during delivery and postpartum care, which in turn will
lead to increased maternal survivability.

Public health relevance
PROJECT NARRATIVE This research introduces the Maternal Obstetrics Monitoring System (MOMS), a technology designed to improve early detection of postpartum hemorrhage (PPH), a leading cause of maternal death. By continuously monitoring vital signs and performing advanced analysis of the measurements, MOMS aims to identify significant blood loss in new mothers more effectively, potentially enhancing maternal health and reducing fatalities from PPH.